Vimentin Phospho-Malleability is Critical for Maintaining Stemness and Metastatic Properties

Project Summary
Metastasis remains a major obstacle in the treatment of breast cancer. A key contributor to metastasis is the
epithelial-to-mesenchymal transition (EMT) program. During EMT, cancer cells gain mesenchymal, migratory,
invasive, and stem cell properties. Cancer stem cells (CSCs) play crucial roles in metastatic progression, cancer
recurrence, and chemoresistance. There is an urgent need for CSC-targeting therapies to combat recurrence
and prevent metastasis. The premiere strategy to exploit the vulnerabilities of CSCs is to identify essential factors
that support the stemness phenotype. Recent research has shown that the EMT process does not move cells
between the binary “epithelial” and “mesenchymal” states. Instead, it is a continuum, and the cells can maintain
both epithelial and mesenchymal characteristics (hybrid E/M) and possess high cellular plasticity and stemness.
During EMT, changes in intermediate filaments, particularly upregulation of the mesenchymal-associated
filament protein vimentin, have been documented. However, the role of vimentin in EMT and stemness and the
consequence of co-expression of vimentin and cytokeratin (CK) in hybrid E/M cells with high stemness are not
known. Besides, the function of vimentin is regulated through dynamic phosphorylation and dephosphorylation
on critical sites, also known as “vimentin phospho-malleability. Preliminary data show that inhibiting phospho-
malleability of vimentin serine-56 (S56) inhibits stemness and induces multinucleation in triple-negative breast
cancer (TNBC) cells. It does not affect cancer cells with epithelial phenotypes, which do not express vimentin,
or fibroblasts, which only express vimentin. Among the various phosphorylation sites, the phospho-malleability
of S56 alone can induce multinucleation and inhibit stemness. Therefore, we hypothesize that vimentin S56
phospho-malleability is critical for maintaining the stemness of carcinoma cells expressing vimentin,
and it is a driver of metastasis. Interfering with vimentin S56 phosphorylation will result in selective
elimination of CSCs, inhibition of metastasis, and increased chemo-sensitivity. We propose the following
aims to test this hypothesis: (1) Characterize how vimentin S56 phospho-malleability influences EMT and stem
cell properties. (2) Define how the interaction between phospho-malleable vimentin and CK affects stemness in
hybrid E/M cells with plasticity. (3) Determine the importance of vimentin S56 phospho-malleability on
metastasis. Through innovative experiments using hybrid E/M cell lines, we will identify signaling pathways and
vimentin-interacting proteins in the context of vimentin S56 phospho-malleability. Using patient TNBC samples,
syngeneic tumor xenografts, and human patient-derived xenografts, we will demonstrate the biological
importance of vimentin S56 phospho-malleability for stemness in vitro and metastasis in vivo. Understanding the
importance of vimentin S56 phospho-malleability and the impact of impairing this will aid in developing novel
EMT and CSC-targeting therapies to treat metastasis-prone TNBCs.

Public health relevance
Project Narrative The epithelial-mesenchymal transition (EMT) program endows breast cancer cells with stemness, therapy resistance and metastatic competence. The intermediate filament protein vimentin serves an important biological role in sustaining cells that have undergone EMT, and regulated changes in its phosphorylation status (termed “phospho-malleability”) are critical for its function. The proposed studies aim to link vimentin phospho-malleability uniquely to cancer stem cells and develop strategies to treat metastasis, including increasing sensitivity to commonly used chemotherapeutic drugs.